Myopia and the Visual Environment

During postnatal development when the eye is still growing, an “emmetropization mechanism” uses the
eye's refractive error to regulate the growth of the scleral shell to match the axial length of the eye to the focal
plane. Despite this, in over 40% of Americans and up to 96% of groups in East Asia, the eye becomes too long
for its own optics and is thus myopic. Even low amounts of myopia raise the risk of developing blinding
conditions and refractive surgery does not change this. Thus, effective strategies to slow eye growth and
reduce the prevalence of myopia are needed.
One possible factor in the increasing incidence of myopia is the difference in the visual environment - the
"image statistics" - between natural and man-made worlds, but to date there has been no good way to test this.
This project will use a novel experimental technique and tree shrews, small diurnal mammals closely related to
primates, to answer this question.
Specific Aim 1. Determine the anti-myopia effectiveness of a range of real-world visual scenes. We will
explore whether different visual scenes do or do not significantly affect emmetropization.
Specific Aim 2: Develop an improved Repeated Low-level Red Light (RLRL) anti-myopia therapy.
Recent results of `low level' red light therapy have shown impressive anti-myopia results, but these therapies
are not low level but exceed established laser safety standards. Of the existing animal models only tree
shrews and non-human primates have myopia reduced by red light; we will here attempt to develop more
effective and safer short-time-exposure anti-myopia red light therapies.
Specific Aim 3: Develop objective recommendations for lighting spectra. It is increasingly apparent that
the spectrum of ambient light has powerful effects on refractive development, and common lighting sources
vary widely in their spectrum. We will attempt to determine if different lighting spectra could be a risk factor for
myopia.

Public health relevance
Myopia (nearsightedness) affects over 40% of the US adult population and about one billion people worldwide, which is a serious public health issue because the increased eye growth of myopia greatly raises the risk of developing blinding conditions. It has been previously proposed that the difference in the visual experience between natural and man-made environments could be a contributing factor. We will attempt to determine the aspects of the visual environment that could contribute to the epidemic of myopia, and develop a novel anti- myopia therapy, using as an animal model the close-to-primate tree shrew.